Task Order 1: The Interventional Agent Development Services Program

The Interventional Agent Development Services program provides services to facilitate preclinical development of therapeutics and new in vivo diagnostics for infectious disease-causing pathogens and/or toxins, such as imaging and skin test reagents. Services include: lead identification and development; chemistry and manufacturing; in vitro and in vivo preclinical safety, toxicology and biokinetics; and preclinical development, planning and evaluation.

Public health relevance
Public Health Relevance: Specific Aims: Ebola virus. Translational research.